Web-enabled social interaction to delay cognitive decline among seniors with MCI: Phase I Administrative Supplement

Project Summary Larger social networks and more frequent social interactions are found to be associated with lower incidence of dementia in observational studies. Increasing social interaction may be a promising intervention for increasing cognitive reserve and sustaining the cognitive well-being of older adults. In our previous randomized controlled behavioral clinical trial, we developed a conversation-based social interaction cognitive stimulation protocol delivered by trained interviewers through personal computers, webcams, and a user-friendly interactive Internet interface with a touch screen (ClinicalTrials.gov:NCT01571427). Daily 30-minute face-to-face communications were conducted over a 6- week trial period in the intervention group. Despite a small sample size, this pilot study (completed 6/30/2014) demonstrated feasibility, high adherence in an elderly population (mean age 80 years) and efficacy in language-based executive functions among the intervention group in comparison to the control group. Based upon these positive results, we propose a Phase I trial to advance development of this intervention. Primary aim (Aim 1) is to examine the efficacy of our intervention on cognitive functions among the target group - those aged 75 and older with MCI and limited opportunities of social interactions. Our primary outcome is a global cognitive function measured by Montreal Cognitive Assessment tests (MoCA) and secondary outcomes are cognitive domains in language-based executive and memory functions. These cognitive outcome results are cross-validated by NIH toolbox cognitive battery. Exploratory outcomes include: a targeted IADL function (medication use and adherence) and emotional well-being. Person-specific levels of social interactions (i.e., average conversation outside of the trial) will be monitored and controlled in the analyses. Exploratory Aim 2 is to examine whether the intervention could lead to changes in speech and language characteristics over time by analyzing recorded daily conversational sessions, based on our promising cross-sectional findings in this area. Exploratory Aim 3 is to examine underlying mechanisms of efficacy by assessing pre- and post- trial changes measured by fMRI connectivity for targeted networks including the default mode network (DMN), the dorsal attention network (DAN), and the salience network (SN). A total of 144 MCI subjects will be recruited and randomized at Portland, Oregon, and Detroit, Michigan. Half of the eligible participants will be randomly selected and invited to participate in the brain imaging study. Increasing daily social contact through communication technologies could offer a cost-effective home- based prevention that could slow cognitive decline, delay the onset of AD, and thereby reduce the overall societal burden of dementia. The oldest old is the fastest growing segment of the population in most developed countries, and face the highest risk of developing dementia and social isolation (risk factors of adverse health outcomes). User-friendly sustainable prevention approaches are urgently needed in this population.

Public health relevance
Project Narrative Faced with an aging population and a growing number of people with Alzheimer's Disease (AD), delaying the onset of AD for a few years could result in a large reduction of the prevalence. After a successful completion of our previous pilot project funded by the NIH R01 mechanism, this proposed Phase I study examines conversational engagement as a means to improve cognitive functions among subjects aged 75 and older with Mild Cognitive Impairment (MCI) and limited opportunities of social interactions. The project is of high public health significance in that few effective, low-cost interventions exist for this vulnerable subpopulation.